The role of long noncoding RNAs in acute myeloid leukemia

PROJECT SUMMARY/ABSTRACT
Over the past 40 years, the standard therapy for acute myeloid leukemia (AML), a highly fatal blood cancer,
remains a combination of chemo drugs such as cytarabine and an anthracycline. Drug resistance in AML inevi-
tably occurs over time. While it is evident that drug resistance and AML burdens are often associated downreg-
ulation of tumor-suppressor transcription factors and the manifestation of oncogenic transcription factor fusions,
therapeutic approaches directly focused on these pivotal biomolecules remains a technical challenge. Our long-
term goals are to identify molecular regulators and partners of cancer-associated transcription factors and to
understand how they cross-regulate in cancer, thereby utilizing this understanding for preventative and thera-
peutic purposes. The overall objective of this proposal is to understand the role and the mechanism underlying
noncoding RNA deregulation in primary and relapsed AML. We recently discovered and characterized a PU.1
enhancer RNA that is capable of inducing myeloid cell differentiation while inhibiting cell growth. We also dis-
covered that the noncoding RNA is inhibited by RUNX1-ETO, a transcription factor fusion that is derived from
one of the most frequent chromosomal translocations associated with AML. We further revealed that it is inhibited
relapsed AML patients. Therefore, we propose that PU.1 regulatory RNAs acts as RNA modulators of the
RUNX1-ETO/PU.1 axis and are important RNA regulators in both primary and relapsed AML. Toward that end,
my lab has generated chemo-resistant AML cell models, and we plan to pursue the following specific aims: 1)
Determine the role of the RNA in primary and relapsed AML, and 2) Define the mechanism underlying its dereg-
ulation in AML. These aims will be achieved by using a variety of approaches including RNA interactions and
gene regulation via chromatin structure with the use of transcriptomic and genomic data from AML patients,
drug-resistant AML cell lines and AML mouse models. Completion of these aims will provide an important insight
into the functions of enhancer RNAs in primary and relapsed AML and provide a scientific basis for modulating
activities of tumor-suppressor transcription factors as well as oncogenic fusion protein. There is the promise that
regulatory RNAs could be utilized in AML treatment. Ultimately, this could be expected to result in the develop-
ment of novel RNA-based drugs to circumvent the current challenge in targeting transcription factors and their
oncogenic derivatives in cancer therapy.

Public health relevance
PROJECT NARRATIVE Drug resistance and Acute Myeloid Leukemia burdens are associated downregulation of tumor-suppressing pro- teins and the manifestation of tumor-promoting protein fusions, but therapeutic approaches directly focused on these pivotal biomolecules remains a technical challenge. This proposal aims to investigate the roles and mech- anisms underlying RNA deregulation in primary and relapsed Acute Myeloid Leukemia. Findings from this ex- ploratory study will lead to the development of a larger grant providing the scientific basis for a novel RNA-based therapeutic for the disease that is poorly treated.